Semantic-based auditory attention decoder using Large Language Model

SUMMARY
Hearing loss is one of the leading mid-life risk factors for dementia, contributing to 11% of cases globally.
Dementia affects 50 million people worldwide, projected to reach 152 million by 2050, with annual costs of $1
trillion. While hearing aids and cochlear implants (CIs) are increasingly used to treat sensorineural hearing loss,
these devices must do more than only amplify all the sound, including noise. They need to enhance the signal-
to-noise ratio and prevent cognitive overload for understanding speech in noise (SiN). CI users show varying
speech perception outcomes, especially in noisy environments, as understanding SiN involves complex sensory
and cognitive processes. Even some individuals with normal hearing thresholds struggle with SiN. Difficulty in
speech perception in noise can lead to social isolation, which may contribute to the development of dementia.
This study proposes to start developing technology that decodes how the brain processes meaning with the
listener's attention by using the existing datasets of electroencephalography (EEG), a method that measures
brain signals. This technology will be able to enhance the sound of the target speaker in a conversation by using
the decoded attention while filtering out unwanted speech with noise. Previous research on EEG attentional
decoding focused on speech envelope, derived from the overall shape of the speech amplitude over time,
neglecting key elements like meaning and context, which are crucial cues in real-world environments. To better
understand and decode the brain when we listen to speech in noise, we should also involve brain areas
responsible for semantic processing, which will lead to effective neuro-driven hearing amplification.
Building on earlier work involving continuous language reconstruction from functional Magnetic Resonance
Imaging (fMRI) recordings, our approach separates speech signals in noisy settings and decodes which one is
being focused on, achieving the same result as natural language decoding but with potentially greater accuracy
and effectiveness. EEG offer higher temporal resolution than fMRI, allowing the interpretation of about two words
per second, while requiring feature extraction from multiple brain regions involved in semantic processing A large
language model (LLM) will predict the brain's semantic processing features from transcribed conversations. A
decision model will then compare these predicted features with actual brain data to identify the conversation that
best matches the current semantic processing, determining which conversation is being attended to.
The study has two key aims: Aim 1 is to develop algorithms that separate speech signals and cluster transcribed
conversations, mimicking auditory object formation in brain. Aim 2 focuses on LLM-based attention decoding to
extract semantic processing features from EEG data and clustered conversations, to identify the attended
conversation. This research will provide the foundation for future neuro-steered hearing devices to assist people
with hearing loss or CAPD. Dementia can impair cognition through auditory processing issues. Our proposed
technology, which supports auditory neural circuits, may enhance social interactions and help prevent dementia.

Public health relevance
NARRATIVE Hearing loss is one of the top two mid-life risk factors for dementia, which can be exacerbated by social isolation resulting from difficulty in speech perception in noise. This proposed study develops technology to enhance listener’s speech perception in noise by modeling semantic and attention processing in the brain, focusing on separating speech conversations and decoding attended target conversations using electroencephalography (EEG). Successful completion of this study will lay the foundation for future research aimed at developing neuro- steered hearing devices to help individuals with hearing loss or those who struggle in noisy environments, which will benefit millions of hard of hearing people.